Three-dimensional Nonlinear Structured Illumination for Live Imaging with 80 nm resolution

Project Abstract
This proposal seeks to develop a microscope capable of live imaging with 80 nm lateral resolution through the
development of Three-dimensional Nonlinear Structured Illumination Microscopy. Single Molecule
Localization Microscopy can offer unprecedented resolution down to 10 nm but requires 10,000 to 100,000
raw images and, therefore, is not amenable to fast live imaging. Stimulated Emission Depletion Microscopy can
achieve ~ 50 nm resolution in live cells and rapid imaging over small (~1 µm2) fields of view but because it is a
point scanning technique becomes too slow when the field of view increases. STED also requires high
intensities reducing its attractiveness for live imaging. RESOLFT microscopy and associated techniques have
shown promising results, achieving ~ 80 nm resolution in live samples but are also slow because they require
lateral sample scanning. Structured Illumination Microscopy (SIM) is an attractive approach for live super-
resolution imaging because it requires relatively few raw images, no lateral scanning of the sample is required,
and the excitation intensity can be low. Linear SIM can achieve ~ 120 nm resolution and live imaging has been
demonstrated in both two dimensions and three dimensions with the fastest frame rates for 2D SIM over 50
frames per second. Nonlinear SIM can theoretically achieve unlimited resolution and imaging with 40 nm
resolution has been demonstrated in two dimensions. Live two-dimensional NSIM has been demonstrated at
2.8 frames per second with 62 nm resolution.
Three-dimensional Nonlinear SIM has yet to be demonstrated. The development of live 3D NSIM with 2D
frame rates exceeding 4 frames per second will fill a need for high-resolution live imaging over large fields of
view up to ~ 100 µm × 100 µm, allowing cellular structures such as filopodia, vesicles, and mitochondria to be
resolved in three-dimensions. To accomplish this we will develop a new Structured Illumination Pattern
generator optical design and novel Adaptive Optics Techniques to achieve the best optical performance
allowing fast aberration-free imaging in cells and thin tissue sections.

Public health relevance
Project Narrative We propose to develop a new microscope capable of live superresolution imaging. This microscope will make it possible to image dynamic subcellular processes with 80 nm resolution, allowing biologists to study evolving processes within live cells and tissue sections. By allowing biologists to gain a better understanding of the dynamics of subcellular structures, this project will help elucidate the mechanisms of disease.